Measurement-Based Transition Assistance (MBTA): Evaluating the Promise of a Web-Based Approach to Promote Veterans' Support Seeking

Background: There is a growing recognition that Veterans’ broader vocational, financial, and social
circumstances have substantial implications for their health and health care. These circumstances include
factors such as whether a Veteran has a job, can pay his or her bills, and has a strong social support network.
Although some Veterans seek help when they experience challenges in these life domains, many do not. One
factor that stands in the way of Veterans’ help-seeking is lack of knowledge, both with regard to how severe
challenges must be to warrant help-seeking and what resources are available to address these challenges. If
not addressed, Veterans’ readjustment challenges may become chronic, escalate in severity, and negatively
influence more aspects of Veterans’ lives over time and thus, become more difficult to intervene on.
Significance: This study will provide a preliminary examination of the potential benefit of Measurement-Based
Transition Assistance (MBTA) in promoting Veterans’ help-seeking. MBTA involves providing individualized
feedback on areas in which Veterans would benefit from additional support, along with personalized
recommendations for relevant programs, services, and supports. If effective, this scalable, population-based
intervention strategy could be used independently or in conjunction with other help-seeking promotion
approaches to interrupt high-risk trajectories before they lead to chronic maladjustment and risk for suicide.
Innovation and Impact: While there has been substantial attention to the importance of promoting Veterans’
use of mental health care, we are not aware of any broad, measurement-based effort to enhance Veterans’
willingness to seek help for multiple areas of unmet need. In addition, most intervention strategies are targeted
to the needs of Veterans with chronic patterns of functional impairment and poor health rather than Veterans
who experience initial readjustment challenges as they adapt to post-military life. The current project is
innovative in its evaluation of a self-administered, population-based approach to raise Veterans’ awareness of
areas in which they may benefit from additional support and to connect them with relevant resources. Given
that MBTA may be most beneficial to Veterans who experience initial readjustment challenges as they adapt to
post-military life, this intervention will be evaluated among Veterans who have recently left military service.
Specific Aim: Aim 1 is to refine MBTA based on input from VA stakeholders (n=6) and qualitative interviews
with Veterans (n=12). A key focus of this aim is to determine the optimal approach for presenting results and
recommended resources. Aim 2 is to evaluate the feasibility, acceptability, and preliminary effectiveness of
MBTA in promoting Veterans’ support-seeking by testing this intervention in a sample of 60 Veterans.
Methodology: The proposed work will be guided by established methods for intervention development and
implementation that emphasize user-centered design principles and iterative cycles of refinement and pilot
testing to enhance MBTA’s effectiveness and scalability. After refining MBTA based on feedback from VA
stakeholders and Veterans (Aim 1), a national sample of Veterans will be randomized to MBTA or an
assessment-only condition in a pilot RCT (Aim 2). The MBTA assessment will be comprised of validated
measures of Veterans’ status, functioning, and satisfaction across life domains, along with well-established
mental health screeners. Veterans in the MBTA condition will receive a user-friendly web-based report that
summarizes areas of unmet need, as well as tailored recommendations for relevant resources. Feasibility and
acceptability will be evaluated based on participation and completion rates, as well as satisfaction and usability
ratings. We will also examine preliminary evidence for effectiveness by comparing pre-post changes in
support-seeking outcomes for Veterans in intervention and control conditions.
Next Steps/Implementation: This pilot study will inform a subsequent IIR proposal for a fully powered RCT to
confirm the effectiveness of MBTA and to evaluate strategies to promote its dissemination and implementation.

Public health relevance
Although some Veterans seek help when they experience post-military readjustment challenges, many do not. One factor that stands in the way of Veterans’ willingness to seek help for these challenges is their lack of knowledge, both with regard to how severe challenges must be to warrant help-seeking and what resources are available to address these challenges. Measurement-Based Transition Assistance (MBTA) aims to address these barriers to help-seeking by providing Veterans with individualized feedback on areas in which they would benefit from additional support with regard to their health, vocational, financial, and social circumstances, along with personalized recommendations for relevant programs, services, and supports. If effective, this scalable, population-based intervention strategy could be used independently or in conjunction with other approaches to enhancing Veterans’ help-seeking to interrupt high-risk trajectories before they lead to chronic maladjustment and increased risk for suicide.